Impact of Circulating Myeloid Cell Clusters on Anti-Tumor Immunity

Durable outcomes in subsets of solid cancer patients treated with immune checkpoint inhibitors (ICI) or adoptive
cell transfer (ACT) immunotherapy has driven interest in gaining a better understanding of resistance
mechanisms that could identify novel druggable targets. Myeloid-derived suppressor cells (MDSC) have
emerged as one such barrier based on their ability to inhibit innate and adaptive immunity. While elevated blood
MDSC are recognized as a poor prognostic indicator in cancer patients, it is widely thought that the main effector
site for MDSC is within the tumor microenvironment (TME). This is in line with the well-documented contact-
dependent mechanisms involving short-lived intermediates that underlie known mechanisms of T cell
suppression by MDSC. Our published and preliminary studies enlarge on this view, showing that MDSC also
function outside the TME through an unprecedented mechanism of intravascular immune suppression. The
proposed study builds on our discovery that circulating MDSC initiate contact-dependent cleavage of the L-
selectin homing receptor on target T cells that substantially reduces antigen-driven expansion of cytotoxic T cells
in lymph nodes. We further found that L-selectin loss coincides with the formation of stable MDSC clusters in the
blood of murine tumor models and advanced cancer patients. We term these new structures circulating myeloid
cell (CMC) clusters. These observations led us to hypothesize that CMC clusters are an unrecognized functional
niche for systemic immune suppression in cancer. To test this hypothesis, we will first determine if blood-borne
MDSC target not only naïve T cells, but more broadly attack stem cell memory and central memory T cells and
natural killer cells that each require L-selectin for their antitumor activity. Secondly, we will determine if CMC
clusters are the active site of L-selectin cleavage by using a multipronged genetic approach to examine L-selectin
fate following disruption of MDSC-T cell conjugate formation in vivo. These mechanistic studies center on β2
integrins that are highly expressed by MDSC but are normally inactive on leukocytes in fast-flowing blood under
non-pathological conditions. Thirdly, we will examine the translational relevance of CMC clusters during ICI or
ACT therapy in a preclinical model in which blood is the primary effector site for MDSC due to their exclusion
from the TME (by blocking chemokine-directed trafficking) and spleen (by splenectomy). We will deplete
circulating MDSC in this model using antibodies or a clinically relevant liver-X-receptor agonist that induces
MDSC-intrinsic apoptosis to establish if blood-borne MDSC contribute to therapeutic resistance. Complementary
studies will test the hypothesis that combining the analysis of circulating MDSC with CMC clusters and/or T cell
L-selectin will formulate an immunosuppressive signature that predicts response to first-line therapy in metastatic
cancer patients. The proposed studies will provide new insights into an unprecedented function of circulating
myeloid cells and could lead to the consideration of CMC clusters as a functional biomarker for prognostication
or preselection of patients that would benefit from MDSC-depleting regimens during cancer immunotherapy.

Public health relevance
Project Narrative Immunosuppressive myeloid cells are recognized as a significant barrier to the efficacy of immunotherapies in cancer patients although their precise site of action is not fully understood. Our laboratory discovered that myeloid cells interact with anticancer immune cells directly within the blood, forming previously unrecognized ‘circulating myeloid cell (CMC) clusters’ that we propose instigate global immune suppression. Our proposed research has the potential to define CMC clusters as a novel mechanism of immune suppression, thereby implicating these cellular conjugates as a blood-based biomarker to guide treatment decisions to improve patient responses to anticancer agents.